Hematopoietic Growth Factors and Chronic Stroke

DESCRIPTION (provided by applicant): Stroke, a neurological disorder with a high incidence in the elderly, is a leading cause of long-term disability in adults worldwide. Stroke is also an enormous public health problem and a serious public financial burden in the United States. Chronic stroke is identified as the period beyond 3-6 months after stroke onset. Currently, no pharmaceutical treatment is available for chronic stroke victims. Stem cell factor (SCF) and granulocyte- colony stimulating factor (G-CSF) are hematopoietic growth factors (HGFs) that regulate blood cell production and mobilize bone marrow stem cells (BMSCs) into the blood. Our recent publications have shown that the receptors for SCF and G-CSF are expressed by neurons, that both SCF and G-CSF can pass through the blood-brain barrier, and, more importantly, that SCF in combination with G-CSF (SCFCSF) shows therapeutic benefits for chronic stroke in a rat model of stroke. However, it remains entirely unknown how SCFCSF repairs a permanently damaged brain during chronic stroke. The objective of this project is to address this unanswered question. Supported by considerable preliminary data, the central hypothesis is that neuronal network remodeling contributes to SCFCSF-induced functional recovery in chronic stroke and that the neuronal network remodeling is accomplished by the direct effects of SCFCSF on neurons and the indirect effects via BMSCs. Using neuronal and BMSC cultures together with stroke models in aged spontaneously hypertensive rats and in aged wild type or transgenic C57 BL mice expressing yellow or cyan fluorescent proteins only in neurons (Thy-1-YFP, Thy-1-CFP), and bone marrow transplantation to track BMSCs, this hypothesis will be tested by pursuing two specific aims. Aim #1 is to determine whether SCF CSF-induced functional benefits in chronic stroke are dependent upon MEK/ERK and PI3k/Akt pathway- mediated neuronal network remodeling. Western blots, cell signaling blockade, RNA interference, 2-photon live imaging and neurological deficit examinations will be used. Aim #2 is to identify the role of the S100A8/A9 chemical gradient established by SCFCSF in homing BMSCs to the brain and to determine the contribution of the BMSCs to SCFCSF-induced functional recovery from chronic stroke. BMSC migration assays, S100A8/A9 gene silencing by RNA interference, and sensorimotor functional evaluation will be utilized. The proposed research is significant because it will advance and extend understanding of how HGFs repair the brain after permanent damage by stroke. Additionally, it will significantly contribute to the development of a unique therapeutic strategy for treatment of chronic stroke. This contribution is in keeping with the NIH mission to reduce national and personal burdens caused by illness and disability.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed study focuses on a highly important, but under-investigated topic: a new therapeutic strategy to treat chronic stroke in the aged population. This research is directly relevant to public health. The findings can provide fresh insights into the contribution of hematopoietic growth factors in brain repair. Additionally, this knowledge may also lead to the development of new treatments for other neurological disorders and neurodegenerative diseases. PROJECT NARRATIVE The proposed study focuses on a highly important, but under-investigated topic: a new therapeutic strategy to treat chronic stroke in the aged population. This research is directly relevant to public health. The findings can provide fresh insights into the contribution of hematopoietic growth factors in brain repair. Additionally, this knowledge may also lead to the development of new treatments for other neurological disorders and neurodegenerative diseases. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Stroke, which mainly attacks the elderly, is the leading cause of adult permanent disability worldwide. Currently, there is no pharmaceutical therapy for treatment of chronic stroke. Recently, the use of G-CSF alone or in combination with SCF to treat ischemic stroke has been actively investigated. We were the first to demonstrate that SCF+G-CSF treatment during chronic stroke facilitates functional recovery in a rat model of stroke. However, the mechanism by which SCF+G-CSF treatment improves functional outcome in chronic stroke remains elusive. Such knowledge is vital to the development of a therapeutic strategy for chronic stroke. The objective of this project is, therefore, to determine how the SCF+G-CSF repairs the brain during chronic stroke. Our central hypothesis is that SCF+G-CSF-induced functional restoration in chronic stroke is linked to the direct effects of these hematopoietic growth factors (HGFs) on neurons and also to their indirect effects via bone marrow stem cells (BMSCs). This central hypothesis is based on extensive preliminary data gathered in our laboratory, including recent publications relating to the expression of the receptors for SCF and G-CSF in the neurons of the adult brain, the permeability of the brain to SCF and G-CSF, and the contribution of the SCF+G-CSF treatment to neuronal regeneration and cerebral vascular regeneration through BMSCs. Using both in vitro and in vivo approaches and using aged animals, we plan to test our central hypothesis and achieve the objective of this application by pursuing the following two specific aims: Specific Aim ¿: To define the contribution of neuronal network remodeling in SCF+G-CSF-induced functional recovery. We have evidence that SCF+G-CSF promotes neurite outgrowth and neuronal network formation and that the MEK/ERK and PI3k/Akt signaling pathways are required for SCF+G-CSF-induced neurite outgrowth. Numerous studies support that neuronal network remodeling plays a key role in functional recovery after stroke. We have demonstrated that dendritic spine density and population of mushroom-type spines in the peri-infarct cortex are increased by SCF+G-CSF treatment in chronic stroke, that a normal pattern of neuronal circuitry can be re-established by SCF+G-CSF treatment during chronic stroke, and that the SCF+G-CSF-treated rats show a stable and long-term functional recovery. Therefore, we hypothesize that SCF+G-CSF enhances neurite outgrowth and new synaptic connections through the MEK/ERK and PI3k/Akt pathways and that the SCF+G-CSF-induced neuronal network remodeling contributes to functional recovery in the chronic stroke phase. Our experiments are designed to determine how SCF+G-CSF regulates neurite outgrowth via the MEK/ERK and PI3k/Akt pathways, whether this regulation can be evidenced through 2- photon live imaging, and whether SCF+G-CSF-induced functional restoration in chronic stroke is dependent upon the neuronal network remodeling by SCF+G-CSF via MEK/ERK and PI3k/Akt pathways. Specific Aim ¿¿: To determine the contribution of homing bone marrow stem cells into the brain in SCF+G-CSF-induced functional recovery. Our considerable evidence supports that SCF+G-CSF treatment in chronic stroke causes an upregulation of S100 A8/A9 (chemoattractants) gene expression, an elevation of S100 A8/A9 protein in the brain, and an increase in bone marrow-derived cell (BMDC) penetration into the brain, and that S100 A8/A9 induce BMSC migration in vitro. Significantly, we have discovered a causal link between the SCF+G-CSF treatment, the S100A8/A9 increase, and the BMDC recruitment in the brain of chronic stroke. We, therefore, hypothesize that SCF+G-CSF induces an S100 A8/A9 gradient in the brain, that this gradient is the key element for homing BMSCs into the brain, and that the BMSC recruitment in the brain is critically involved in brain repair during chronic stroke. Experiments are designed to determine which types of cells contribute to the gradient formation in the brain and how the chemical gradient is built up, whether entry of BMSCs into the brain depends on the S100 A8/A9 gradient, and whether homing BMSCs into the brain is required for SCF+G-CSF-induced functional improvement. This proposed research is innovative, because it provides new insights into the role of HGFs in repairing a permanently damaged brain during chronic stroke. This research complements and reinforces a unique strategy for treatment of chronic stroke, which was originally developed by our group. Key abbreviations: AMPA, α-amino-3-hydroxyl-5-methl-4-isoxazole-propionic acid; ANOVA, analysis of variance; BBB, blood-brain barrier; BMSC, bone marrow stem cell; BMDC, bone marrow-derived cells; CCA, common carotid artery; CFP, cyan fluorescent protein; ELISA, enzyme linked immunoSorbent assay; G-CSF, granulocyte-colony stimulating factor; GFP, green fluorescent protein; HGF, hematopoietic growth factor; ICV, intracerebroventricular; MCA, middle cerebral artery; MNCs, mononuclear cells; NF-κB, nuclear factor κB; NMDA, N-methyl-D-aspartate; PBS, phosphate-buffered saline; qRT-PCR, real-time reverse transcription PCR; RT- PCR, reverse transcriptase-polymerase chain reaction; S100 A8/A9, S100 calcium binding protein A8/A9; s.c., subcutaneous injection; SCF, stem cell factor; SHRs, spontaneously hypertensive rats; siRNA, small interfering RNA; YFP, yellow fluorescent protein.